2024 ASXL-Related Disorders Scientific Conference and Family Meeting

Project Summary
The ASXL-Related Disorders are ultra-rare neurodevelopmental and congenital malformation
syndromes caused by variants in one of the ASXL genes (Bohring-Opitz Syndrome: ASXL1, Shashi-Pena
Syndrome: ASXL2, Bainbridge-Ropers Syndrome: ASXL3). The ASXL genes regulate transcription of the Hox
genes and are considered “readers” of the epigenetic code by playing a role in histone modification and
chromatin regulation. The clinical variability of these syndromes ranges from autism and overgrowth to profound
intellectual disabilities and growth failure. In the majority of these individuals, multiple organ systems are
affected, including the neurologic system (non-verbal, hypotonia, seizures, dysautonomia), psychiatric
functioning (behavioral disorders, anxiety, ADHD, OCD, autism spectrum), vision (retinal anomalies, optic nerve
dysplasia, high myopia), and gastrointestinal (chronic vomiting, feeding intolerance, gallstones), thereby
requiring a high level of care. There is also an increased risk for Wilms tumor and hepatoblastoma in ASXL1.
This NIH R13 grant is for the ASXL-Related Disorders Scientific Conference and Family Meeting,
which will be a 4-day international symposium at the Kennedy Krieger Institute in Baltimore, MD from July 18-
21, 2024. The event will include clinical and scientific presentations from experts on these disorders. It will also
involve a trainee poster session, research room to provide opportunities for participation in clinical research
studies, and family events. The goals of the meeting are: 1) To further knowledge about the natural history and
clinical management of the ASXL-Related Disorders; 2) To expand the research network and share data from
the international scientific community on the ASXL disorders; 3) To increase cross-talk and collaboration
between scientists, clinicians, and families in an effort to build on our basic understanding about the pathogenicity
of the ASXL genes; 4) To further clinical translational efforts for the ASXL conditions by developing an
infrastructure for clinical trials through developing biomarkers, collecting biologic samples, and natural history
data; 5) To foster a family network that provides a safety net for families and allows for the improved holistic care
for all ASXL families.
This symposium focuses on genetic conditions that have a significant impact on the health and well-being
of the entire family unit. While these conditions are congenital, primarily impacting children, a growing number
of individuals are surviving into adulthood. Supporting the health and development of children throughout their
lifespan while recognizing the role of the entire family’s health, is a critical mission of the Eunice Kennedy Shriver
National Institute of Child Health and Human Development (NICHD).

Public health relevance
Project Narrative The ASXL-Related Disorders Scientific Conference and Family Meeting will serve to increase medical and scientific knowledge about syndromes caused by variants in the ASXL genes and to improve the quality of medical care provided to these individuals. By improving clinical management of these systemic, neurocognitive disorders, the aim is to decrease suffering and increase quality of life for impacted individuals and their families.